Identify new regulators of outer membrane vesicle entry into macrophages

PROJECT SUMMARY
Outer membrane vesicles (OMVs) released by extracellular Gram-negative bacteria can deliver
lipopolysaccharide (LPS) and other bacterial molecules to the cytosol of macrophages. OMVs enter
macrophages through endocytosis and reach the endosome of macrophages. Subsequently, components of
OMVs including LPS cross the endosomal membrane and reach the cytosol to trigger pyroptosis, an
inflammatory form of cell death. While the downstream pyroptotic signaling steps were previously
characterized, the upstream stage of OMV entry into macrophages remains largely unknown. The goal of this
project is to bridge this major knowledge gap. In our preliminary studies, we established assays to measure
OMV-induced pyroptosis in RAW 264.7 macrophages. Using these assays, we performed an unbiased
genome-wide CRISPR genetic screen to dissect OMV-induced pyroptosis. The screen isolated known
mediators of pyroptosis and a large number of candidate genes not previously linked to pyroptosis or OMV
function. In this proposed research, we will validate and characterize the candidate genes isolated in the
CRISPR screen to identify new regulators of OMV entry into macrophages. These experiments are expected
to establish mediators of OMV-macrophage interaction, OMV endocytosis, and translocation of OMV
components across the endosomal membrane. These exploratory studies will shed light on the molecular
basis of OMV entry into macrophages and will broaden our knowledge of inflammatory responses. Insights
gleaned from this research will facilitate the development of safer and more effective strategies to combat
bacterial infection and inflammatory diseases.

Public health relevance
PROJECT NARRATIVE This project is expected to identify factors required for the entry of outer membrane vesicles (OMVs) of Gram- negative bacteria into macrophages. The findings will expand our knowledge of bacterial infection and innate immunity, and will facilitate the development of safer and more effective strategies to combat bacterial infection and inflammatory diseases.